The VA Genomics Learning Health System: Implementing genomic medicine across diverse veteran communities

PROJECT SUMMARY
The Veterans Health Administration of the Department of Veterans Affairs (VA) is the largest and most diverse
learning health system (LHS) in the US, caring for more than 9 million patients annually in every state and US
territory. A full quarter of VA healthcare enrollees nationally live in HRSA-designated Health Professional
Shortage Areas (HPSAs). VA patients also have a greater burden of physical and mental health comorbidities
than the general US population. Nonetheless, a focus on performance measurement and improvement has
kept the quality of VA care as high or higher than in the private sector. This quality has been achieved by VA’s
innovation in implementation science and embodiment of LHS attributes, leveraging its vast clinical electronic
health record (EHR) data, robust informatics infrastructure, and patient-centered focus to continually evaluate
and improve patient care based on real-time monitoring and feedback. The VA is also a national leader in
clinical genomic medicine, including telegenetics, pharmacogenomics, and precision oncology. VA innovations
in genomic medicine have been driven by its LHS ecosystem of data-informed continuous quality improvement
(CQI), innovation, and national dissemination of implementation strategies found to be effective at local and
regional levels. In this project, VA will bring its national LHS infrastructure and genomic medicine
implementation strategies to a network of other genomics-enabled LHS. The network will conduct
implementation projects centered on a mainstream model for delivery of genomic medicine that promotes the
use of evidence-based, guideline-concordant genetic testing by frontline clinicians. The VA genomics-enabled
LHS will contribute to this network effort by 1) identifying and sharing with the network an implementation
approach and strategies with high potential for implementation across diverse healthcare systems, including
under-resourced settings; 2) proposing three implementation trials for network-wide conduct
(pharmacogenomic testing to optimize pharmacotherapy, germline testing to inform cancer treatment, and EHR
identification and germline testing to diagnose unrecognized monogenic disease); and 3) working with the
network to conduct implementation projects of genomic medicine interventions across a spectrum of clinical
conditions and patient characteristics within the VA genomics-enabled LHS and its community, recruiting
underserved populations and geographic areas. Through participation in this network, the VA will disseminate
its deep LHS expertise to other clinical sites and in turn bring the learnings from the larger network to improve
the genomic health care and outcomes of the nation’s military veterans, their families, and communities.

Public health relevance
PROJECT NARRATIVE The Veterans Health Administration (VA) will join a network of other genomics-enabled learning health systems to conduct network-wide implementation projects promoting the uptake of evidence-based genomic medicine interventions. Projects will include pharmacogenomic testing to optimize pharmacotherapy, germline testing to inform cancer treatment, use of electronic medical records to identify patients with undiagnosed genetic diseases, or others selected by the network. These projects will determine the best strategies for implementing genomic medicine across the nation’s health systems, including in medically underserved areas.